Using DNA hydrogels to mimic, exploit, and fundamentally investigate extracellular matrices

Project Summary
Synthetic hydrogel biomaterials hold great potential as cell culture scaffolds, but their complexity falls
short of mimicking the intricacies of biological systems, limiting their clinical efficacy. To overcome this, the goal
of this MIRA application is to develop a versatile, DNA-based synthetic extracellular matrix (ECM) mimic that
can be precisely controlled, manipulated, and degraded. This research seeks to not only enhance regenerative
medicine applications but also provide deeper insights into cell biology and ECM interactions. Our hypothesis is
that by harnessing DNA's unique tertiary and quaternary structural properties, we can emulate complex
mechanical features of the ECM in a controllable and orthogonal manner. DNA's distinct role in biology and its
absence in native ECM make it biocompatible and well-suited as a synthetic cell matrix. However, cost and
scalability have limited the use of DNA-based ECM mimics. Fortunately, recent advancements in large-scale
production of cGMP-grade dsDNA for vaccines have made it dramatically more accessible and provide a starting
material ripe for rapid clinical translation. We have already made significant progress in producing high-purity
dsDNA and developing DNA-based hydrogels with ECM-like properties, including non-linear elasticity and
tunable viscoelasticity. These hydrogels exhibit promise in encapsulating cells without cytotoxicity and offer the
potential for controlling tissue-mimetic properties. Our future research program is divided into three thrusts. In
Thrust 1, we aim to develop DNA hydrogels with tunable ECM-mimetic properties and study their interactions
with embedded cells. We will independently explore tuning non-linear elasticity and viscoelasticity, providing
valuable insights into cell behavior under hard to emulate mechanical conditions. Thrust 2 focuses on dynamic
modulation of DNA hydrogel properties, allowing for the controllable actuation of changes in elasticity and
viscoelasticity over time. This approach mimics the dynamic manipulation of ECM during biological processes
such as disease onset or healing and aims to provide a deeper understanding of cell responses to changing
mechanical properties. In Thrust 3, we investigate the expression and release of small proteins and growth
factors directly from the DNA matrix, enhancing nutrient transport and enabling final release from the synthetic
matrix. Overall, this research program aims to demonstrate the broad utility of DNA-based hydrogels as ECM
mimics applications in regenerative medicine and fundamental studies of biophysics. These hydrogels have the
potential to revolutionize other fields, from tissue engineering to drug delivery, biosensing, and beyond.

Public health relevance
Project Narrative The influence of tissue mechanics on cell behavior has been widely acknowledged, especially in the contexts of wound healing, disease advancement, and regenerative medicine, however, there is a critical shortage of materials that can effectively elucidate the intricate relationship between tissue mechanics and cellular responses. In this proposal, our primary goal is to enhance the applicability of hydrogel biomaterials by harnessing clinically approved plasmid deoxyribonucleic acid (DNA) to create materials that emulate the properties of living tissues. This approach will allow us to integrate unique structural and functional attributes inspired by the versatile and dynamic characteristics of DNA enabling fundamental understanding of cell- environment homeostasis research and facilitating transition into clinical applications.